Investigating the role of TMEM106b genetics and pathology in Alzheimer’s disease, LATE and FTLD

PROJECT SUMMARY/ABSTRACT
Filaments derived from transmembrane protein 106B (TMEM106B) were recently discovered to represent a
novel pathological hallmark in a range of neurodegenerative disorders, including TDP-43 proteinopathies,
synucleinopathies, and tauopathies. Notably, TMEM106B genetic variants are linked to risk of frontotemporal
lobar degeneration with TDP-43 inclusions (FTLD-TDP), particularly cases with progranulin (GRN) and
chromosome 9 open reading frame 72 (C9ORF72) mutations, and limbic-predominant age-related TDP-43
encephalopathy (LATE) neuropathologic change. TMEM106B variants also associate with cognitive decline in
patients with amyotrophic lateral sclerosis. While several single nucleotide polymorphisms (SNPs) in
TMEM106B have been identified and linked to disease risk, only one (rs3173615) introduces a coding change
(p.T185S) and it is in high linkage disequilibrium with other risk SNPs. To investigate the intriguing idea that
rs3173615 could modulate disease risk through regulation of TMEM106B deposition, we developed an
antibody against the TMEM106B filament core sequence. Consistent with recent reports, we detected
TMEM106B-positive filaments in the sarkosyl-insoluble fraction from FTLD-TDP and LATE patients.
Remarkably, we also observed increased accumulation of insoluble TMEM106B in FTLD-TDP patients
homozygous for the rs3173615 risk allele (encoding threonine at residue 185 instead of serine). Collectively,
these findings support the hypothesis that TMEM106B aggregation explains the link between genetic variation
at the TMEM106B locus and disease risk – and we suspect that it could also explain potential links between
rs3173615, TDP-43 proteinopathy, and cognitive decline. We also speculate that differences in TMEM106B
accumulation contribute to clinical and pathologic heterogeneity in both FTLD and LATE. Moreover, given that
LATE is associated with greater hypometabolism on [18F] fluorodeoxyglucose PET (FDG-PET) in the frontal
lobe, a region populated by TMEM106B fibrils, we predict that rs3173615 genotype will also associate with
neuroimaging measures of neurodegeneration. In this project, we will investigate the impact of rs3173615
genotype on TMEM106B aggregation and assess whether it associates with TDP-43 proteinopathy and clinical
outcomes. We will also explore the mechanism by which the rs3173615 coding variant affects TMEM106B fibril
formation, as well as the potential functional consequences of TMEM106B genetic variation and fibril
accumulation. Our approach to the latter will be two-fold: as a candidate-based approach, we will determine
whether TMEM106B genetic variants impact lysosomal function in neurons, and as an unbiased approach, we
will use proteomic analyses to build protein-protein interaction and co-aggregation networks from the soluble
and insoluble fractions of patient brains, focusing on differences observed in carriers of the T185 allele versus
carriers of the S185 protective genotype.

Public health relevance
PROJECT NARRATIVE Transmembrane protein 106B (TMEM106B) is a protein that normally localizes to the lysosome and has been genetically linked to frontotemporal dementia (FTD). Recently, filaments formed from TMEM106B have been discovered in several disorders, including FTD and Alzheimer’s disease. The current project is focused on characterizing and defining patterns of TMEM106B aggregation in the brain, in addition to understanding the functional consequences of this filament deposition on the disease course.